Multimodal microscope for intraoperative assessment of breast surgical margins

Project Summary/Abstract Physical Sciences, Inc. (PSI), in collaboration with MD Anderson Cancer Center (MDACC) and Caliber ID, Rochester, NY proposes to develop a novel technology for real-time assessment of surgical margins on breast cancer lumpectomy specimens and provide immediate feedback to the surgeon. A multimodal microscope will be used in conjunction with a high sensitivity cancer targeting agent to detect positive margins on lumpectomy specimens. Enhanced contrast fluorescence imaging will be first applied to identify potentially positive margins, while combined high-resolution confocal microscopy-optical coherence tomography imaging will be then used to visualize tissue morphology at the sub-cellular scale and confirm or rule out cancer presence. In Phase I we demonstrated the suitability of this technology for positive cancer margins detection on surgical specimens in a benchtop study. Based on Phase I observations and conclusions we propose to further improve this technology in Phase II and perform a larger scale clinical validation study at the MD Anderson Cancer Center, Houston, TX. Furthermore, a commercialization strategy for this technology will be developed and preliminary steps towards reaching this goal will be taken.

Public health relevance
Project Narrative Enhanced contrast fluorescence imaging and high-resolution optical microscopy are powerful optical technologies for biological tissue imaging. The combination of these technologies into an integrated microscope, together with the use of a highly sensitive and specific contrast agent, will enable very effective real-time assessment of surgical specimens for positive cancer margins. Therefore, this technology will help to increase the success rate of cancer surgeries. Besides reducing the risk of cancer recurrence and thus significantly reducing US healthcare costs, it will also reduce emotional costs for both patient and family.